Innate Immune Activation in Malaria

ABSTRACT: Acute infection with malaria is often accompanied by the symptoms of a systemic cytokine storm.
These symptoms result from a systemic inflammatory response via the activation of phagocytes. The overall
goal of our ongoing project is to define the mechanisms of innate immune activation and regulation that account
for the clinical symptoms and complications of malaria. This grant is a renewal of R01 AI079293. This RO1 has
been highly productive having resulted in 40 publications including 16 peer-reviewed manuscripts of original
work in the latest funding period (9 of these directly related to the grant, an additional 5 papers were supported
by grant-related infrastructure in Brazil). Over the last decade, we have defined what we believe to be the
principal “malaria toxins” and their cognate receptors: parasite AT-rich DNA, immune complexes, hemozoin, free
heme, and GPI anchors. We found that these ligands drive Toll-like receptors (TLRs 2, 3, 4, 9), NOD-like
receptors (NLRP3, NLRP12), absent in melanoma 2 (AIM2), and the cGAS-STING pathway. Our work led to
recognition that a cytosolic DNA binding protein Cnbp, regulates IL12b and IFNg and, under certain conditions,
type I interferons. We have described the phenomena of innate immune memory in malaria, which is one part
of an epigenetic process that may both protect the human host or, under certain conditions, might result in severe
malaria (especially if accompanied by bacterial infection). More recently, we have identified several lncRNAs in
malaria-stimulated phagocytes, many of which might regulate clinical disease. Thus, we have accomplished
most of what we set out to do 5 years ago. In this renewal, we plan to focus on identifying the most basic
methods by which the innate immune system is regulated in malaria by combining cell culture studies, in vitro
mouse work with the analysis of patient samples. There are three Aims. The major hypothesis of the grant is
that the innate immune response is highly regulated via epigenetic modifications of chromatin as well as at the
transcriptional level. This regulation involves the interaction of lymphoid cells with phagocytes, resulting in innate
immune training and a variety of epigenetic changes. The epigenetic changes involve the modification of
chromatin, alterations of chromatin accessibility (Aim 1). In addition, inflammatory signals during malaria result
in the generation of long non-coding RNAs including LUCAT-1 and LIMIT, whose roles we will explore in detail
in vitro, in a LUCAT-1 KO mouse and in human clinical samples (Aim 2). Finally, we will define the role of a
transcriptional regulator known as Cnbp, a nucleic acid binding protein that we initially thought to be a DNA
sensor. Cnbp has proven to be involved in regulating IL12beta transcription and expression via its interaction
with c-Rel and the IL12 promoter (Aim 3). In all of the Aims described briefly above, we will analyze leukocytes
from febrile patients with malaria (both P. vivax and P falciparum) from our site in Porto Velho, Brazil. This grant
is an ambitious project built upon the successful completion of two previously ambitious grants. Over the next
funding cycle, we hope to contribute significantly more to our knowledge of innate immunity in malaria.

Public health relevance
Project Narrative Malaria is caused by Plasmodium, a parasite that is spread by mosquitoes, and the disease is often characterized by a high fever and other flu-like symptoms. The disease affects all organs of the body and can cause a heightened immune response that can lead to death; the World Health Organization reported that in 2017 there were ~435,000 deaths due to malaria. To better treat and prevent malaria, the goal of this proposal is to understand how the body’s immune system detects Plasmodium and identify the genes and pathways responsible for responding to and eliminating this parasite.